Research Coordinating Center to Reduce Disparities in Multiple Chronic Diseases (RCC RD-MCD)

SUMMARY
Significant disparities in preventing, treating, and managing multiple chronic diseases exist along intersecting
racial, cultural, socio-economic, and vulnerable population contextual lines. Meaningful community
engagement and culturally informed multilevel approaches are required to effectively reduce these disparities.
The UCSF Research Coordinating Center (RCC) leverages our significant expertise, experience, and capacity
in community-engaged research, disparities research, program implementation with underserved and
vulnerable populations, data science, and major chronic diseases to serve and support a nationwide disparities
research consortium through coordinating and technical assistance activities. This Supplement will contribute
to multiple goals of the National Artificial Intelligence Research Resource (NAIRR) (e.g. capacity building,
trustworthy AI, workforce diversity) by enhancing these two existing RCC Specific Aims:
Aim-2) Implement RD-MCD Consortium-wide Common Data Element Development, Collection,
Integration, Curation, Analysis, and Sharing; and
Aim-4) Facilitate and Monitor Vibrant Community-Engaged Research.
During this Supplement, the RCC will
(a) Expand data on chronic disease and social determinant of health data in health disparity populations.
(b) Test the community (neighborhood) de-identification process's robustness via AI-assisted re-identification
testing and risk analysis.
(c) Demonstrate a case study of using core common data elements to enhance data set interoperability and
utilization of resulting aggregated data sets.
(d) Develop community-facing training materials and conduct training sessions to enhance broader community
awareness of AI.
(e) Participate in ScHARe Think-a-Thons to highlight using HEAN data in research.

Public health relevance
This project will leverage and pivot UCSF’s significant expertise, experience, and capacity in community-engaged research, disparities research, program implementation experience with populations that are underserved and vulnerable, data science, and major chronic diseases to create a nationwide research coordinating center and technical assistance center to support a network of NIMHD funded P50 centers to reduce multiple chronic disease related disparities in underserved and vulnerable populations.